Training in the Multiscale and Multimodal Analysis of Biomarkers in Alzheimer’s Disease

PROJECT SUMMARY/ABSTRACT
Recognizing the critical need for a broad range of expertise in biomarker analysis at several levels of analysis,
we propose a unique postdoctoral training program titled “Training for the Multiscale and Multimodal Analysis of
Biomarkers in Alzheimer’s Disease” (AD). USC is home to leading experts who utilize biomarkers in their work
investigating AD through a myriad of methods and analyses. Drawing from USC’s eminent resources and
expertise, this proposal will focus on preparing investigators for independent research careers in the multiscale
and multimodal analysis of biomarkers in AD, by integrating molecular and cellular methods, imaging tools and
informatics, quantitative methods for clinical trials research, and large-scale population analyses. Our proposed
training program draws preceptors and faculty from 12 schools, departments, institutes, and centers at USC,
fulfilling these methodological areas of expertise: USC Mark and Mary Stevens Neuroimaging and Informatics
Institute (INI) in the Keck School of Medicine (KSoM); Zilkha Neurogenetic Institute (ZNI) in the KSoM;
Department of Neurology in the KSoM; Department of Neurological Surgery in the KSoM; Department of
Radiology in KSoM; Alzheimer's Therapeutic Research Institute in the KSoM; Department of Population and
Public Health Sciences at the KSoM; Department of Economics in the Dana and David Dornsife College of
Letters, Arts and Sciences; Center for Economic and Social Research in the Dana and David Dornsife College
of Letters, Arts and Sciences; Institute for Technology and Medical Systems Innovation (ITEMS), a joint initiative
between Keck School of Medicine and Viterbi School of Engineering; Leonard D. Schaeffer Center for Health
Policy and Economics, a unique collaboration between the USC Sol Price School of Public Policy and School of
Pharmacy; and Leonard Davis School of Gerontology. Trainees will complete coursework, lab rotations, and
career development activities, such as seminar series, instruction for problem solving, communication, time
management, and leadership skills, and instruction and training in grant writing. Trainees will become conversant
in all thematic areas and will be able to effectively collaborate outside of their own particular area of expertise.
Specifically, the USC Training for the Multiscale and Multimodal Analysis of Biomarkers in AD will aim to: equip
trainees with a combination of skills to conduct multiscale and multimodal analyses of biomarkers in AD by
providing tailored, didactic research education opportunities to further the research potential of trainees; facilitate
eminent research in the multiscale and multimodal analysis of biomarkers in AD by trainees, including the
development of research ideas, execution of research projects, and dissemination of research findings; establish
among trainees a collaborative and multidisciplinary team approach to advance research in the multiscale and
multimodal analysis of biomarkers in AD; and successfully transition trainees to independent research careers,
including securing their own research funding.

Public health relevance
PROJECT NARRATIVE USC’s “Training for the Multiscale and Multimodal Analysis of Biomarkers in Alzheimer’s Disease” (AD) will focus on preparing postdoctoral investigators for independent research careers by integrating four areas of methodologies to illuminate various aspects of biomarkers in AD at differing scales: molecular and cellular methods, imaging tools and informatics, quantitative methods for clinical trials research, and large-scale population analyses. Trainees will complete coursework and career development activities such as lab rotations, seminars, instruction for problem solving, communication, time management, and leadership skills, as well as career guidance, including instruction and training in grant writing, in order to apply successfully for future fellowships and career development and independent research support.